Personalized Cystic Fibrosis Therapy and Research Center

SUMMARY:
The administrative core will promote interaction among researchers and clinicians with interest in CF/CFTR-
related research. The implementation of this thematic program, Personalized Medicine in CF, will be its most
important goal. Toward this end, the Core will develop a strategic plan; oversee the operations at the Center
including budget, core services, the P/F Program, enrichment programs, and membership management. The
administration will help shape an excellent research environment for CF/CFTR-related studies by promoting
and fostering collaboration between the basic, translational, and clinical investigators. The Administrative Core
will provide support to three biomedical cores for their facilities and services and will be proactive in developing
patient outreach programs. The ultimate goal is to develop personalized therapy for individuals with CF to
improve their quality or life and wellbeing.